PFAS accelerate atherosclerosis through modulation of bile acid metabolism

PROJECT SUMMARY
Cardiovascular diseases are the leading cause of death in the United States and worldwide, and atherosclerotic
heart disease is particular burdensome. Per- and polyfluoroalkyl substances (PFAS) are a class of ubiquitous
man-made chemicals that have been associated with increased risk factors for cardiometabolic disease (i.e.,
increased circulating cholesterol), or major outcomes related to atherosclerosis including stroke/heart attacks in
epidemiological studies. No studies have reported on PFAS accelerated atherosclerosis using rodent models.
Recent rodent studies have shown PFAS can increase circulating cholesterol, but these studies have relied
primarily on wildtype mice which display lipoprotein cholesterol fraction patterns (VLDL, LDL, HDL) that are
opposite of humans, and which do not develop lesions within the aorta. To circumvent this problem and to have
an experimental model from which results can be directly extrapolated to humans, we will use Low Density
Lipoprotein Receptor deficient mice (Ldlr -/-), which have lipid profiles like humans, to determine if PFAS-
mediated increases in cholesterol levels lead to pathological atherosclerosis. Recently, we published that
wildtype mice fed an atherogenic diet and exposed to a simple mixture of 5 environmentally relevant PFAS
(PFOS, PFOA, PFNA, PFHxS, and GenX) for 12 weeks resulted in increased circulating cholesterol and bile
acids. In preliminary studies, we followed the same exposure paradigm and observed increased circulating
cholesterol in Ldlr -/- mice. Here, we propose to extend our initial observations using a simple PFAS mixture to
a full factorial design and examine atherosclerotic lesion formation. Circulating cholesterol levels can be
modulated through mechanisms related to dietary cholesterol absorption, de-novo cholesterol synthesis, and
fecal excretion. Our preliminary studies show that Ldlr -/- mice exposed to the mixture show decreased bile acid
excretion and induction of reuptake transporters in the ileum (especially apical sodium dependent bile acid
transporter; ASBT). Our proposed studies will use pharmaceuticals selective for ASBT and mass labeled sterols
to confirm ASBT induction is critical. Finally, to validate some of these observations in a human cohort, we
recently measured PFAS in serum from the Anniston Community Health Surveys (ACHS) and we reported that
residents were highly exposed to PFOS, and we now propose to measure bile acids in stored samples. We will
use mixture methods to show 1) PFAS mixtures statistically correlate with increased cholesterol, and 2) these
associations are mediated through increases in circulating bile acids. We hypothesize that PFAS accelerate
atherosclerosis by altering cholesterol excretion as bile acids. Our specific aims are: 1) To test the hypothesis
that mixtures of environmentally relevant PFAS accelerate atherosclerosis in Ldlr -/- mice. 2) To test the
hypothesis that PFAS disrupts bile acid reuptake leading to increases in circulating cholesterol through ASBT-
related mechanisms. 3) To examine the association between PFAS mixtures and circulating bile acids and test
if that the association between PFAS mixtures and cholesterol can be explained by increases in these.

Public health relevance
PROJECT NARRATIVE We hypothesize that PFAS mixtures can increase circulating cholesterol levels and increase atherosclerosis risk. Results from our transdisciplinary mixture studies will identify disruption of bile acid metabolism as a causative link between PFAS exposures and cardiovascular disease risk.